Structural Analysis of Macromolecular Complexes by Electron Microscopy

Our earlier cryo-electron microscopic studies have provided detailed insights into the three-dimensional (3D) organization of icosahedral PDH complexes (Milne et al. EMBO J., 2002; Milne et al., J. Biol. Chem., 2006). We established that E1 or E3 components form an outer shell with an annular gap of 75-90 Angstrom between the outer surface of the E2 core and the regions at each 3-fold vertex where the inner linker joins the peripheral subunit binding domain to which E1 and E3 bind. The creation of this annular space or gap provides an improved means of substrate channeling, both by restricting the volume that the lipoyl domains of the E2 core must sweep through in cycling between the E1, E2 and E3 active sites and by lessening potentially deleterious interactions of a lipoyl domain with E1 or E3 as it shuttles back and forth between the E2 core and the outer layer of E1 and E3 enzymes. The methods developed in the course of this work have served as a platform for studies on the structure of HIV and SIV envelope glycoproteins and have resulted in a number of new structures that we have reported over the last year. In particular, the structures of both soluble and membrane-bound forms of trimeric Env have led to new and unexpected insights into mechanisms of HIV entry into target cells. Our contribution to these studies has resulted in significant methodological advances for automation of image processing and structure refinement, and these have led to a 10-fold increase in the speed of determining structures of these membrane proteins displayed on intact viruses using cryo-electron tomography. These studies have produced the first structures of trimeric Env immunogens and will be invaluable for rational vaccine design.